Collagen Assembly in Intervertebral disc

ABSTRACT
In this competing renewal of AR057025, we expand the scope and now focus on collagen in nucleus
pulposus (NP) tissue of the interertebral disc. We propose to 1) define the role of NP-specific post-
translational modifications within type II collagen chains in regulating the diameter of fibrils. 2) establish a
molecular fingerprint for cross-linked collagen heterofibril assembly as a biomarker for native and in vitro
generated NP tissue. By the age of fifty, 85 percent of the US population shows evidence of a compromised
collagen network and disc herniation. As the population ages, such biomarkers to evaluate the quality of
regenerated NP neo-tissue is significant, offering new hope in the treatment of disc disease.
The fibrillar network that frames the jelly-like nucleus pulposus is made up of types II, IX and XI collagen,
the same gene products that characterize hyaline cartilage. The mechanism that drives these molecules to
heteropolymerize as thin diameter fibrils in nucleus pulposus but as thicker diameter fibrils in hyaline cartilage
is still unclear. Recent evidence convincingly correlates the assembly of thin (<20nm) collagen fibrils in NP with
elevated levels of an unique type II collagen post-translational modification, the 3-hydroxylation of proline
residue 944 (P944). In hyaline cartilage where the 3-hydroxylation of P944 is nearly lacking, thicker (20-
100nm) fibrils are observed. We will use the RCS-LTC cell line as a model system to address this mechanism.
This cell line, originally derived from a spinal neoplasm, assembles types II, IX, XI collagens into cross-
linked thin diameter collagen fibrils in a jelly-like extracellular matrix. Elevated levels of the prolyl 3-hydroxylase
2 (P3H2) enzyme correlated with the highly 3-hydroxylated P944 residues in type II collagen chains deposited
in the matrix. We will use the CRISPR/Cas9 gene editing system to knock out the P3H2 gene, in combination
with mass spectrometry and electron microscopy to define a role for 3-hydroxyproline residues in type II
collagen fibril diameter regulation. We intend to aggressively pursue this concept in order to understand how
cells modulate the thickness of collagen fibrils in NP and other type II collagen based tissues. This is important
from both a basic biology and tissue regeneration perspective. Furthermore, employing biochemical
methodology generated from our original RO1 grant, we aim to fingerprint the pattern of collagen inter-type II-
IX-XI cross-linking in native and in vitro cultured nucleus pulposus neo-tissue. This will provide a screen for
normal matrix assembly and serve as a basis for future regeneration studies. Electron microscopy, mass
spectrometry and biomechanics will be used to determine the thickness and post-translational quality of the
fibrils and function. The goal is to ascertain the ability of the neo-tissues to assemble tissue-specific 3-
hydroxyproline modified type II collagen molecules into a network typical of native nucleus pulposus. Essential
information for next-generation NP neo-tissue with high collagen content will be gained. This is significant as a
nascent, accurately cross-linked, type II-IX-XI collagen template is crucial to the growth of the fibril.

Public health relevance
NARRATIVE It is estimated that 80% of adults in the US have some sort of back pain with nearly $150 billion being spent in healthcare costs to treat the symptoms. A healthy back depends upon the ability of the nucleus pulposus within the intervertebral disc of the spine to act as a shock absorber. The nucleus pulposus is a jelly-like tissue that is framed by a highly cross-linked collagen network. Breakdown of this collagen network, as can happen during normal aging or by trauma, results in herniation, loss of normal disc function and severe back pain. The objective of this study is 1) to determine if the extracellular matrix of cultured nucleus pulposus cells contains the complex cross-linked collagen network essential to normal nucleus pulposus function and 2) to determine if high levels of 3-hydroxyproline at residue P944 in type II collagen chains is responsible for the thin diameter collagen fibrils typical of this tissue.